Developing Accessible Sleep EEG Growth Charts for Young People

ABSTRACT
Adolescence is a dynamic developmental stage in which health trajectories can pivot, in both negative and
positive directions. A comprehensive understanding of normative adolescent development provides an essential
template for detecting early deviations from maturational trajectories, along with actionable windows in which
intervention can maximally impact health trajectories. In pediatric medicine, height and weight growth charts are
used as a reference to detect abnormal development and alert physicians to intervene. While highly scalable,
height/weight charts do not capture the important neurodevelopmental changes occurring over adolescence. To
be most informative for adolescent risk detection and intervention, we need to map development in modifiable
brain-based metrics that change over adolescence. These measures must be assessable at-scale and predict
health outcomes. We propose that reference models of sleep physiology over adolescence carry high potential
value for early detection of brain-based health risk and subsequent effective intervention. Sleep macro- and
micro-architecture undergoes dramatic change over adolescence; plays an active role in sculpting the structural
and functional maturation of the brain; is associated with myriad sociocultural, environmental, and sex/pubertal
factors; predicts long-term brain, behavior, and health trajectories; and is modifiable with non-invasive
biobehavioral intervention. However, a barrier to wide use of sleep physiology for risk assessment is that
polysomnography, the gold standard measure, is a costly method with limited scalability. Thus, we must validate
accessible methods that measure sleep at home; in doing so, we will reduce barriers to quality health care,
particularly for underserved groups. To improve sleep-based risk assessment in adolescents, our goal is to
create normative growth charts for sleep physiological features in typically developing young people using two
complementary sleep measurement methods: gold-standard polysomnography and a wearable sleep recording
device. First, we will examine age trends in sleep physiology in typically developing young people (N~1300, 9-
26yr) with polysomnography data harmonized across multiple existing cohorts (Aim 1). In tandem, we will use
the wearable device to collect home sleep recordings in typically developing young people (N=500, 9-26yr). A
subset of this sample (N=250 participants) will also complete polysomnography. We will use measurement-in-
error modeling to establish a functional relationship between sleep outcomes derived from polysomnography
and the wearable device (Aim 2). Then, we will recapitulate normative age trends in sleep physiology with the
data obtained from the wearable device and evaluate potential sociocultural, environmental, and sex/pubertal
modifiers of sleep physiology age trends (Aim 3). Completion of our aims will provide an essential normative
template for the study of adolescent sleep physiology, tools to improve detection of suboptimal sleep in the real-
word, and a comprehensive understanding of how multiple mechanisms influence age-associated sleep patterns.

Public health relevance
PROJECT NARRATIVE Sleep is a modifiable factor that supports healthy development; the quality and amount of sleep a youth gets is associated with a multitude of long-term health outcomes in adulthood. We propose to develop sleep growth charts of sleep macro- and microarchitecture using a combination of gold-standard, archival polysomnography data and accessible, at-home sleep recording devices. These resulting growth charts will serve as an essential template for the study of adolescent sleep development, improving detection of suboptimal sleep and enhancing personalized interventions.